Multidrug Metabolic Approach to Improve Exercise and Skeletal Muscle Oxidative Capacity in HFpEF

SUMMARY: Heart Failure with Preserved Ejection Fraction (HFpEF) is on pace to become the dominant form
of heart failure, yet we have no treatments to offer patients, leaving them limited in terms of exercise tolerance
and quality of life. While much attention has been paid to the myocardium, data suggest that abnormalities in
skeletal muscle (SkM) oxygen utilization also contribute to exertional intolerance in this condition. Moreover,
decreased nitric oxide (NO) bioavailability has been demonstrated in HFpEF patients. NO augments SkM
oxygen delivery and plays a key role in enhancing fatty acid oxidation (FAO), both of which are important for
submaximal exercise endurance. Recently, sodium-glucose cotransporter-2 inhibitors such as empagliflozin
(EMPA) have demonstrated remarkable benefits in other cardiovascular disease patients, though their use in
HFpEF remains unclear. EMPA could be beneficial in HFpEF patients via multiple mechanisms, many of which
target abnormalities identified specifically in HFpEF, including: (a) increasing mitochondrial biogenesis, (b)
increasing FAO, (c) increasing plasma ketone bodies, providing an additional source of acetyl-CoA for energy
production, and (d) increasing blood hemoglobin, augmenting oxygen delivery for any given blood flow.
Moreover, because NO is essential for FAO and a key mediator of exercise SkM blood flow, we propose that
combining EMPA with a NO-donor such as potassium nitrate (KNO3) will lead to improvements in exercise
capacity in HFpEF patients, as compared to EMPA alone or active control.
Our overarching hypothesis is that impaired SkM oxidative phosphorylation capacity (OxPhos) limits
exercise tolerance in HFpEF. We focus on submaximal exercise endurance in this proposal as submaximal
exercise better reflects the level of exertion reached by HFpEF patients during daily activities, is more
dependent on FAO than maximal effort exercise, and is less likely to constrained by cardiac output limitations.
We will test the impact of three interventions in 53 HFpEF participants in a randomized double-blind cross-over
trial: (1) EMPA; (2) EMPA + KNO3; and (3) Potassium chloride (active control). In Aim 1: participants will
undergo cycle ergometry exercise tests. The primary endpoint will be the change in submaximal exercise
endurance. In Aim 2: We will test the impact of our 3 interventions on SkM OxPhos using MRI following
plantar flexion exercise. Novel MRI sequences will also be employed that quantify intramuscular perfusion. In
Aim 3: We will conduct SkM tissue biopsies to assess mitochondrial respiration, the SkM metabolome, and
quantify the SkM proteome, providing in vitro assessments to support our exercise measurements.
Our proposal will target SkM metabolism in HFpEF and comprehensively assess the relationship
between SkM OxPhos and submaximal exercise endurance using complementary techniques. This proposal
has the potential to identify SkM metabolism as an important therapeutic target in this disease for which we
currently have no approved pharmacologic therapies.

Public health relevance
PROJECT NARRATIVE Many people suffer from Heart Failure with Preserved Ejection Fraction (HFpEF), but unfortunately, we do not have any drug treatments that consistently improve a patient’s ability to exercise or his/her quality of life in this syndrome. The goal of this proposal is to test whether improving skeletal muscle metabolism and energy production can improve exercise tolerance in HFpEF patients. We hope that this proposal will identify new ways to treat HFpEF patients, allowing these individuals, who are currently very limited in what they can do and how they feel, to enjoy life more.